Coordination: Swine Somatic Cell Gene Editing Testing Center

PROJECT SUMMARY: COORDINATION SECTION
The role of the Genome Editing Coordination Section will be to manage communication and logistics
associated with Swine SCGE Center. These responsibilities include reporting to NIH and regulatory agencies
when appropriate. These responsibilities also include communication with Center Users, the Program Steering
Committee, and various collaborators. These efforts are in support of refining SOPs additional services for
assessment of safety and efficacy of SCGE systems, reagents, or strategies. These efforts also support
providing testing services to the research community regarding testing of somatic genome editing reagents in
health and disease models. This project will produce novel swine biomedical models that harbor human
genome targets. Our group is ideally suited to provide this testing due to our unique composition of individuals
that are experienced with pig production, swine biomedical models, operate successful labs that routinely test
cutting-edge genome editing technology, and are associated with world-renowned National Swine Resource
and Research Center (NSRRC).